Neighborhood characteristics, GPS-based activity space, and cognitive health

Project Summary/Abstract
This five-year plan for the Pathway to Independence Award will help launch Dr. Jinshil Hyun’s independent
research career focused on environmental/behavioral factors that modify trajectories of cognitive aging and
Alzheimer’s disease and associated dementia (ADRD). Her proposed aims use geospatial and GPS-based
methods to comprehensively characterize the impact of neighborhood on cognitive health. Her proposed
training will supplement her expertise in ambulatory cognition and cognitive aging with a foundation in neuro-
epidemiology (Dr. Lipton), spatial analysis and urban health (Dr. Lovasi), and biostatistics (Dr. Hall). The
proposed research and training plan will leverage rich dataset from the Einstein Aging Study and existing
resources at the Albert Einstein College of Medicine. The findings from this study will identify person- and
contextual-level risk profiles for ADRD, which will ultimately support personalized and population-level
interventions, especially among vulnerable populations.
There have been important advances in our understanding of risk and protective factors for ADRD,
including studies that explore the impact of neighborhood environments on cognition. Although most studies
used data from objective measures of geospatially-defined neighborhoods, individuals’ perception of their
neighborhoods and person-specific experience of neighborhood environments may vary among individuals
even within the same area. This project aims to investigate the influence of neighborhood characteristics,
assessed by (i) objective, geospatially-defined and subjective neighborhood aspects and (ii) GPS-based,
person-specific activity space measures, on cognitive decline, ADRD, and cognitive health disparities. The PI
will process and analyze data collected from the Einstein Aging Study’s annual ecological momentary
assessments battery. Continuous GPS tracking from smartphones will allow to characterize person-specific
neighborhood experiences (i.e., activity space). Cognitive outcomes will be measured by both yearly
conventional neuropsychological tests and smartphone-based ambulatory assessments (6x/day) over 14-day
burst data collection periods each year of follow-up. In the K99 phase, the PI will examine how objective and
subjective neighborhood aspects are associated with cognitive outcomes (Aim 1). In this phase, the PI will also
complete training in spatial analysis, and based on that, will process GPS data and develop/validate activity
space measures. In the R00 phase, the PI will examine the associations of GPS-based activity space with
cognitive and brain health (Aim 2), and subgroup (e.g., biological sex, race, APOE e4) differences in the
associations (Aim 3). Aims 1 to 3 results will provide the basis for an R01 application in the fourth award year.
Keywords: activity space, neighborhood, urban health, GPS, Geographic information system, spatial analysis,
ecological momentary assessments, ambulatory cognition, cognitive aging, ADRD, disparities.

Public health relevance
Project Narrative This project aims to examine the influence of contextual-level neighborhood characteristics and person-specific neighborhood experiences on trajectories of cognitive aging and Alzheimer’s disease and related dementias. The study will also examine neighborhood factors influencing cognitive health disparities. The expected outcomes will guide sustainable behavioral interventions and population-level interventions to promote cognitive health especially among vulnerable populations.